NHLBI BUILD UP TRUST CHALLENGE INITIAL OBLIG HHS-CAOD-2021-NHLBI-001

the Build UP Trust
Challenge Prize Competition (hereafter referred to as “Trust Challenge”). The National Heart, Lung, and Blood Institute (NHLBI) is leading the Trust Challenge, whose objective is to improve engagement with underserved populations (UP) with a focus on increasing research participation and adoption of existing and new tools and strategies to detect, treat, and monitor diseases and disorders.